SBIR TOPIC NCCAM: 001 R AND RS-ALPHA-LIPOIC ACID ANALYTICAL METHODS VALIDATION

This Phase I, SBIR contract is for laboratories with appropriate expertise and facilities to analyze the most common dietary supplements and compare the compositions with what is declared on the product label, certificate of analysis, or other documentation.